Whole Genome Sequencing Diagnostics to Address Antibiotic Resistance

To develop an integrated diagnostic platform that utilizes Whole Genome Sequencing (WGS) to identify bacterial pathogens and predict antibiotic susceptibility directly from blood to help address the problem of antimicrobial resistance.